Interventional Agents Chemistry Services

The Interventional Agents Chemistry Services (IACS) program provides a broad and flexible range of chemistry and manufacturing capabilities to support infectious disease programs from the Lead Optimization stage through Preclinical Development, IND submission, and subsequent clinical and nonclinical studies.